POI-KB: Design and Development of a Knowledgebase for Accelerating Perioperative Organ Injury Research and Translation

Acute perioperative organ injury (POI) causing single- or multiple-organ failure is the leading cause of
mortality and morbidity in surgical patients. Strategies to prevent or treat POI can significantly improve
perioperative outcomes. Despite the intense investigational efforts in POI research, a large gap still exists in
respective domain knowledge crosstalk and research efforts synchronization, which hinders the advancement of
POI research. Therefore, there is an urgent need to develop a knowledge base platform that will bridge the
multidisciplinary and translational gap among health science researchers who identify the important healthcare
issues, basic science researchers who reveal the disease mechanisms underlying POI, and physician scientists
who carry out important clinical trials to bring these preventive/therapeutic interventions to clinical practice.
Interrogating large-scale public data resources offers unprecedented opportunities for advancing organ injury
research. The ability to interrogate large-scale data resources has become a central focus of many research
efforts. While successful data integration efforts have resulted in novel diagnostics, therapies, and prevention
strategies, many data resources remain underutilized. First, researchers often lack even the most basic tools for
navigating this complex data landscape which limits the full potential of leveraging the data for research.
Secondly, researchers may also lack knowledge on what kinds of research questions for a specific topic can be
addressed by those existing data resources. As POI research tends to be multidisciplinary and the lack of a
knowledgebase for POI hinders the effort on leveraging existing public data resources for POI research.
Here, we propose to develop Perioperative Organ Injury Knowledge Base (POI-KB), an innovative
knowledgebase to systematically catalogue and curate POI information from public data resources through a
multidisciplinary team science effort. POI-KB will consist of four components: POI-Ontology – an ontology
capturing biomedical concepts (e.g., diseases, genes, drugs) discovered in relevant POI literature and other
public knowledgebases through formal ontological development process; POI-Graph – a knowledge graph
capturing relations in POI-Ontology through text mining, database fusion, ontologies and network mapping
methods, followed by human verification; POI-Catalyst – a discovery engine for POI to accelerate POI research
by indexing existing resources and datasets using POI-Ontology to facilitate resource discovery and facilitating
hypothesis generation using semantic web technologies; and POI-Portal – a web portal to host tools and
resources developed and foster community engagement for POI-KB. We aim to engage and evaluate POI-KB in
supporting use cases in POI from various research communities across the translational spectrum. We will work
with stakeholders to gather feedback and ensure the POI-KB effectively addresses the needs of both researchers
and clinicians. We will demonstrate the potential of the POI-KB through impactful use cases, generating new
scientific knowledge and mechanistic hypotheses for further testing.

Public health relevance
Project Narrative We will develop a knowledgebase for perioperative organ injury (POI) which aims to catalogue and curate POI information available in public data resources and bridge the multidisciplinary and translational gap with an eventual goal of improving perioperative outcome.